Geroscience Redox Biology Core

The goal of the Geroscience Redox Biology Core is to provide investigators with a coordinated and
comprehensive evaluation of the molecules, pathways, and systems that contribute to oxidative metabolism and
oxidative stress. These analyses include state of the art accurate and sensitive measures of redox and energy
balance as well as oxidative damage, reactive oxygen species production and mitochondrial function. Redox
status and oxidant homeostasis have a major impact on physiologic processes. As a consequence, they
contribute significantly to basic mechanisms of aging as well as a number of age-related diseases, and are key
pathways in geroscience. The Specific Aims for this Core are the following: Specific Aim 1. To perform accurate
and comprehensive analyses of redox status (GSH/GSSG, NADPH/NADP+, NADH/NAD+,), and oxidative stress
and damage markers (lipid peroxidation, e.g., F2-isoprostanes; protein oxidation, e.g., carbonyls; and DNA
oxidation, e.g. 8-oxo-deoxyguanosine). Redox and oxidative damage endpoints are present in limited amounts
and may be unstable. The expertise in the Geroscience Redox Biology Core allows for these analyses to be
performed with the highest possible sensitivity and accuracy. In addition, the analyses the Geroscience Redox
Biology Core provides are especially appropriate for a Research Core because they require costly equipment
and significant technologic expertise that prevents these types of analyses to routine measures in individual
laboratories. Finally, because we are analyzing levels of highly specific biological compounds, our redox and
oxidative damage assays can be applied to tissues or cells from any living organism. Specific Aim 2. To provide
assays of mitochondrial function, energetic status, and reactive oxygen species generation using permeabilized
tissue, isolated mitochondria, and cell culture models. Although these assays require fresh tissue/cells, we have
successfully performed these services for investigators at external sites who can send us small numbers of mice.
Specific Aim 3. To provide in vivo analyses of free radical production, we have expanded the capabilities of the
Geroscience Redox Biology Core in this renewal to include in vivo analyses of redox and energy status, vascular
dysfunction, and tissue structural changes. The Geroscience Redox Biology Core will now provide in vivo redox
analyses of free radical levels and oxygen status using magnetic resonance imaging (MRI) and immuno-spin
trapping (IST). In addition functional MRI (fMRI), will be used for oxygen status and energy status obtained from
tissue-localized phosphorous (31P)- and hydrogen (1H)-MR spectroscopy.
Overall, the Geroscience Redox Biology Core will provide a comprehensive panel of endpoint markers of
redox balance and oxidative stress as well as measures of contributing factors such as mitochondrial function
and free radical generation in vitro and in vivo that can impact many aspects of anging and Geroscience.